The role of DNA damage tolerance pathways in human cells

Project Summary
Accurate DNA replication is essential for genomic stability and cellular homeostasis, and protects against cellular
transformation. Obstacles to DNA replication block the progression of DNA polymerases, arresting replication
forks. Unless efficiently restarted, stalled replication forks can collapse, resulting in generation of DNA breaks,
promoting genomic instability and carcinogenesis. To avoid fork breakage, cells are equipped with mechanisms
to stabilize and restart the fork, thus promoting genomic stability. One important fork restart mechanism involves
rapid re-initiation of DNA synthesis downstream of the lesion, through repriming catalyzed by the PRIMPOL
enzyme, to restore timely DNA replication. This leaves behind a single stranded (ssDNA) gap in the nascent
strand. Accumulation of ssDNA gaps has recently emerged as an important intermediate in DNA damage-
induced cell death, thus potentially determining the cellular hypersensitivity to genotoxic agents (including
cisplatin), particularly in DNA repair-deficient cells. While by themselves ssDNA gaps are not considered
cytotoxic, their accumulation has been associated with formation of cytotoxic double strand DNA breaks (DSBs).
DSBs can also cause genomic rearrangements, representing a main driver a chromosomal instability.
Understanding the basic mechanisms of ssDNA gap repair is crucial for improving human health. However, how
ssDNA gaps are processed into cytotoxic structures represents a major knowledge gap. We have recently
uncovered three new processes involved in ssDNA gap homeostasis, which represent the focus of this
application. Aim 1 will investigate the regulation of PRIMPOL-mediated fork restart by CAF1. We hypothesize
that CAF1 promotes PRIMPOL recruitment to arrested forks to initiate fork repriming. We will measure ssDNA
gap formation using specific cell-based assays and test the impact of CAF1 on PRIMPOL recruitment to stressed
forks using biochemical and imaging approaches. Aim 2 will investigate the suppression of ssDNA gaps by
PARP10. We hypothesize that PARP10, by activating PCNA ubiquitination-mediated TLS, promotes ssDNA gap
filling in response to genotoxic exposures. We will test if PARP10 enhances the PCNA ubiquitination-dependent
recruitment of TLS polymerases for gap filling using cell-based localization and functional assays, and investigate
the functional synergy of PARP10 with the BRCA pathway in chemoresistance. Aim 3 will investigate the
nucleolytic processing of ssDNA gaps into cytotoxic structures. We hypothesize that processing of ssDNA gaps
into DSBs drives genomic instability and cellular toxicity in certain genetic backgrounds such BRCA deficiency.
We will measure the mechanisms and regulation of nuclease engagement to nascent strand gaps in cell-based
imaging assays, and how this functionally impacts genome stability and cell death by measuring chromosomal
integrity and cellular viability. By investigating three novel ssDNA gap processing mechanisms, using state-of-
the-art functional, imaging and genetic approaches, our proposal aims to paint a detailed picture of ssDNA gap
homeostasis, with significant implications on our understanding of genome stability and DNA damage sensitivity.

Public health relevance
Project Narrative Accurate DNA replication is essential for preserving genomic stability and cellular homeostasis. Our proposed work investigates three new mechanisms regulating the repair of gaps in the nascent strand during replication. This will result in better understanding of DNA damage repair and genome integrity, with clinical implications.